The Together Everyone Achieves More Physical Activity Trial (TEAM-PA)

Project Summary/Abstract
The overall goal of this proposal is to expand upon the evaluation of interpersonal mechanisms in an ongoing
group-based physical activity (PA) intervention for inactive African American women, the “Together Everyone
Achieves More Physical Activity” trial (TEAM-PA; R01HL160618). Drawing from Social Cognitive Theory, Self-
Determination Theory, Group Dynamics Theory, and research on an Afro-Centric Worldview, the TEAM-PA trial
targets four group-based interpersonal factors, which are hypothesized to be key interpersonal mechanisms for
promoting total minutes of physical activity per day: collective efficacy, group cohesion, and reciprocal support.
The proposed supplement study aims to expand upon the parent R01 by evaluating in greater depth how
interpersonal factors facilitate changes in physical activity across time using experience sampling methods. Past
efforts to understand interpersonal mechanisms of change for physical activity among African American women
have been limited by primarily using between-person approaches for assessing mediators (e.g., cross-sectional
surveys), which do not fully capture African American women’s lived experiences and fluctuations across time
and contexts. Furthermore, extensive research has demonstrated the importance of support for physical activity
among family and friends among African American women, but such studies rarely adopt an ecological
framework to evaluate the simultaneous impact of support for physical activity across multiple systems (e.g.,
group-based programs, family, friends, community), or the extent to which support for physical activity fluctuates
across time and contexts. Thus, the proposed supplement study seeks to address these limitations by adding
three 7-day waves of experience sampling methods across the 10-week treatment period to better understand
how interpersonal factors (both within the group-based intervention and across participants’ broader support
networks) fluctuate across time and contexts to impact daily physical activity. By evaluating within-person
changes over time and contexts and adopting a systems-level focus, we propose that this approach will better
capture African American women’s lived experiences and provide more comprehensive support for when and
why interpersonal factors promote greater physical activity among African American women. The specific aims
of the proposed supplement study are: to test whether fluctuations in the daily group-based interpersonal factors
(collective efficacy, relatedness, group cohesion, reciprocal support) impact increases in daily total minutes of
physical activity over time [Aim 1]; to evaluate whether fluctuations in the group-based interpersonal factors and
fluctuations in support from one’s broader support network independently impact increases in daily PA across
time [Aim 2]; and to determine whether contextual aspects of support (e.g., network source, type of support,
physical proximity) act as moderators and help to explain when fluctuations in support from one’s broader support
network are most impactful on daily total minutes of PA across time [Aim 3].

Public health relevance
Project Narrative The proposed supplement study aims to expand upon the ongoing “Together Everyone Achieves More Physical Activity” (TEAM-PA) trial by evaluating in greater depth how interpersonal factors facilitate changes in physical activity across time and contexts using experience sampling methods. Understanding when and why interpersonal factors promote changes in physical activity is a critical next step for improving the long-term impact of physical activity interventions.